Pain in Hidradenitis Suppurativa: Adolescent Phenotypes and Perspectives

Project Summary/Abstract
Candidate: This competitive revision to a K23 career development award will prepare Lauren Orenstein,
MD, MSc to conduct studies in adolescent patients with hidradenitis suppurativa (HS), a chronic
inflammatory skin disease characterized by recurrent painful scarring abscesses. She will adapt techniques
to understand their pain mechanisms and develop recommendations for targeted interventions to reduce
adolescents’ pain and prevent progression to chronic opioid use. In addition to the career development
objectives of her original K23, this revision provides mentored experience in multi-site recruitment,
research in pediatric populations, and adolescent stakeholder engagement.
Mentoring and Environment: In addition to her internationally renowned K23 mentorship team, this
competitive revision will add mentorship in pediatric research and adolescent populations from Leslie
Lawley, MD (expertise: pediatric dermatology, validating study instruments in pediatric populations). It will
also establish relationships with community pediatric dermatologists, gynecologists, and surgeons for multi-
site study recruitment. She will continue her ongoing relationships with K23 primary mentors (Rachel
Patzer, PhD MPH and Dio Kavalieratos, PhD), other co-mentors (Suephy Chen, MD MS, Amit Garg, MD,
and Daniel Harper, PhD), and consultants (John Ingram, MA MSc DM FRCP FAcadMedEd, Kimberly
Curseen, MD, and Anne-Marie McKenzie-Brown, MD).
Research: This research aims to address knowledge gaps related to HS pain in adolescents and develop
recommendations for family-centered interventions to alleviate pain and prevent long-term opioid use.
Specific Aims: An ongoing 16-week prospective cohort study in adults will be adapted for adolescents
aged 12-17 years who have moderate-to-severe HS. Comprehensive assessments, including clinical
disease activity, systemic inflammation, and sensory profiles using quantitative sensory testing, will be
used to characterize HS pain mechanisms in adolescents compared to adults, identify pain trajectories,
and optimize pain measurement in adolescents for clinical trials. In a separate study, semi-structured
interviews with adolescents and their parents/guardians will explore unmet needs in HS pain management.
These data will inform a Stakeholder Panel consisting of adult and adolescent HS patients, care partners,
community advocates, and experts in HS, palliative care, and pain management. The panel will use
Intervention Mapping to develop recommendations for designing and evaluating complex interventions
aimed at addressing pain and suffering in adults and adolescents with HS. This study represents one of the
first prospective cohorts of adolescents with HS. It will yield an engaged stakeholder panel with the
preliminary data needed for intervention development in future R01 grant proposals focusing on a unique
window of opportunity in adolescence to prevent progression to chronic opioid dependence.

Public health relevance
PROJECT NARRATIVE Hidradenitis suppurativa (HS) is a common, chronic inflammatory skin disease that causes severe pain, leading to poor quality of life, chronic opioid use, and elevated suicide risk. This competitive revision to a K23 career development plan will examine HS pain mechanisms and trajectories in adolescents and involve adolescents and their parents/guardians in stakeholder-engaged research to begin development of interventions that prevent adolescent’s progression to chronic opioid use. The data generated by this proposal and associated training will enable Dr. Orenstein to become an independent researcher whose work reduces pain in adolescents with serious skin disease and prevents long-term opioid dependence.